Project 2: Human Fetal Prostate and Endocrine Disruption

With an increasing incidence woridwide. prostate adenocarcinoma is the most common non-skin cancer diagnosis and the second leading cause of death in men in the U.S. Estrogenicity during in utero development has been associated with later life risk of prostate adenocarcinoma, raising concern that eariy life exposures to endocrine disrupfing chemicals may be contributing to this disease burden. This pilot project uses xenotransplantafion of human fetal prostate (gestational age 12-22 weeks) as a model to examine the developmental effects of endocrine disrupting chemicals. Following characterization of the maturation sequence in the xenografts, dysregulation of this developmental sequence by estradiol exposure, with and without a second later exposure, will be determined. Histopathological and biomarker assessment will identify estradiol-induced pre-cancerous alterations in ductal morphogenesis, and the longterm effects of estradiol exposure, including the occurrence of prostatic intraepithelial neoplasia, will be identified. Building on this basic characterizafion of the model, early developmental exposures to the environmental endocrine disruptors bisphenol A and genistein will be compared with estradiol for epigenefic modifications. The working hypothesis is: Human fetal prostate xenotransplants respond to estrogenic endocrine disrupting chemical exposure with aberrant differentiation due to altered DNA methylation. Rodents have been useful models for the study of prostate carcinogenesis;however, spontaneous prostate neoplasia in rodents is rare while humans are uniquely suscepfible. Therefore, this project offers the very disfinct advantages of human relevance and enhanced suscepfibility in the evaluafion of environmental impacts on fetal prostate development. The goal of this pilot project is to build a human-based platform to evaluate the developmental origins of later life prostate disease associated with endocrine disrupting chemical exposure, focusing on the underlying epigenefic mechanisms that control disease induction and progression

Public health relevance
The overarching goal of tiiis Formative Center is to develop novel biomarkers for the adverse effects of environmental exposures that impact fetal development and produce childhood and adult disease. Using an interdisciplinary approach, research, educafional. and training intervenfions will be designed to address the concerns that pregnant women, families, and communities have about environmental chemicals and the health oftheir developing children